Center for Neurovascular Engineering Research and adVanced Education (NERVE)

Abstract
The imperative for biomedical engineering research and education is underscored by the widespread prevalence of brain
diseases and disorders, such as Alzheimer's disease (AD). This emphasizes the urgent need for innovative technologies to
advance our understanding, treatment, and prevention efforts. Recent technological convergence, encompassing
organoids, drug delivery, imaging, machine learning, and regenerative medicine, positions biomedical engineering and
imaging to pioneer groundbreaking solutions, ushering in a new era for human brain health. Organoids and nanodevices
hold significant importance on understanding, diagnosing, and treating neurological diseases/disorders. Amid these
advancements, it is crucial to emphasize the importance of cultivating a diverse and skilled workforce, especially from
underrepresented groups (URGs), in the field of biomedical engineering. The proposed establishment, the "Center for
Neurovascular Engineering Research and AdVanced Education (NERVE)," aims to: 1) propel research and education in
biomedical engineering concerning organoid and nanoparticle technologies, 2) enhance capabilities in advanced
imaging/machine learning, and small animal testing, 3) pioneer the first PhD Bioengineering Program at Historically
Black Colleges and Universities (HBCUs), 4) cultivate a diverse workforce encompassing PhD, BS, and MS levels, with a
specific emphasis on underrepresented groups (URGs), and 5) foster a sustainable and innovative ecosystem in
engineering and imaging technologies. This center is built on the strong track record of 1) research on organoid,
nanoparticles, advanced imaging, and neuroscience, 2) education on pioneering BS and MS in Biomedical engineering,
and 3) seamless collaboration across multiple departments, including Bioengineering, Biology, Psychology, and Electrical
Engineering at NC A&T State University (NCAT), in collaboration with the University of Pittsburgh and Washington
University in St. Louis with nationally recognized labs and industry. Benefiting from robust institutional support,
including the Interdisciplinary Bioengineering Center (IBEC) and the PhD Program plan from NCAT, NERVE aims
establish a sustainable hub that transforms brain science and technologies into a lasting ecosystem, charting a course for
the development of the next generation of the bioengineering workforce.

Public health relevance
NERVE, a pioneering biomedical engineering center, aims to advance mini-brain technology and drug delivery system through cutting-edge research, imaging and animal testing capacity building, PhD program establishment, and the cultivation of a diverse workforce, transforming the field for the next generation.